RECOMBINANT HUMAN GROWTH HORMONE IN HIV WASTING

Study of Serostim or placebo for patients with documented HIV infection and body wasting. Evidence of AIDS wasting with documented unintentional weight loss of at least 10%, weight loss less than 90% of ideal body weight, or body mass index <20 kg/m2. Study includes a 4 week observation period, enrollment and study visits up to 48 weeks.